Modeling alcohol toxicity in human hepatocytes

Project Summary
Alcohol contributes to nearly half the liver related deaths in the United States, mostly from cirrhosis
and hepatocellular cancer. Even though large numbers of people misuse alcohol, only a small fraction
develops liver disease. A better understanding of the mechanisms that contribute to hepatocyte damage
from alcohol is clearly warranted.
Mouse models are one tool to further our understanding of the role of alcohol on hepatocytes.
However, in part due to species differences and because human genetic predispositions cannot be modeled
in mice, ethanol studies in mice have been of limited translational use. An alternative approach to study the
effects of alcohol on human hepatocytes are liver chimeric mice. These models are based on the
transplantation of primary human hepatocytes into immunodeficient mice with liver injury, after which the
human cells proliferate and repopulate the mouse liver parenchyma. There are many limitations with these
models, one of them being that only very healthy hepatocytes engraft. Hepatocytes from patients with
inflamed livers or cirrhosis generally fail to engraft, which has limited our ability to create disease-specific
chimeric models. Possible solutions to this problem would be to genetically manipulate primary hepatocytes
or to create chimeric mice with pluripotent stem cells. However, manipulating primary human cells has
remained challenging and pluripotent stem cells have largely failed to reconstitute liver chimeric models.
We have recently created protocols to efficiently engraft a liver chimeric model with induced
pluripotent stem cells or with primary cells that were genetically altered in culture These protocol leads to
chimeric animals in which the majority of the liver has been humanized. In addition we can isolate large
numbers of human hepatocytes from these mice to create primary human hepatocyte cultures that are
stable for months. These advances, combined with a new organoid system, provides us with unique tools to
study various hepatocyte responses to alcohol.
We here propose to combine these advances to test the effects of alcohol on human hepatocytes.
We will use both primary human hepatocytes and pluripotent stem cell-derived hepatocytes to establish
systems of alcohol toxicity in hepatocytes, and test a genetic variant that predisposes humans to develop
alcoholic hepatitis. In addition the new organoid technology will allow us to test the effects of alcohol on
hepatocyte regeneration.
At the completion of these studies we will have established systems with which the effects of long-
term alcohol toxicity on human hepatocytes can be modeled. These systems will further advance the
creation of patient-specific chimeric models for alcoholic liver disease, and may advance the use of stem
cell therapies for therapeutic use in patients.

Public health relevance
Project Narrative Genetically predisposed human hepatocyte responses to alcohol cannot readily be studied in mice with a humanized liver because cells from patients fail to engraft. We here propose to create human hepatocytes from pluripotent stem cells or genetically manipulated primary cells to study the effects of alcohol on human hepatocytes. This project will result in human systems to study alcohol toxicity in human hepatocytes.